Mechanotransduction Mechanisms of Cardiac Growth and Regeneration

Project Summary
More than a million Americans experience a heart attack each year causing irreversible
damage to their heart muscle. Current therapies prolong survival by protecting
remaining cardiomyocytes but are unable to overcome the fundamental problem of
replacing lost cardiomyocytes. Thus, understanding which molecular pathways govern
cardiomyocyte proliferation is a high priority in the effort to explore new treatments for
heart failure. The transition from hyperplastic to hypertrophic growth in the postnatal
heart is accompanied by dynamic remodeling of cell-cell and cell-extracellular matrix
(ECM) adhesion structures, suggesting that cell adhesion/cytoskeletal changes play a
critical role in myocardial growth control. In support of this idea our lab found that
modifying the connection between N-cadherin and the actin cytoskeleton leads to
accumulation of Yap in the nucleus, increase cardiomyocyte proliferation, and improved
cardiac function following myocardial infarction in mice. The overall goal of this new
project is to elucidate the molecular mechanisms regulating the dynamic nature and
interplay between myocardial cell-cell and cell-ECM interactions and the ensuing
downstream signals that ultimately control cardiomyocyte proliferation. Aim 1 will
determine the requirement for post-translational modification of a cytoskeletal adaptor
protein in junction maturation, cardiomyocyte differentiation and cell cycle arrest in the
neonatal heart, Aim 2 will determine whether inhibiting phosphorylation of this
cytoskeletal adaptor protein, either genetically or pharmacologically, will promote heart
muscle regeneration following myocardial infarction, and Aim 3 will elucidate
mechanical consequences of altering VCL function in human iPSC-derived
cardiomyocytes. Completion of these preclinical proof-of-concept studies will determine
whether targeting cell adhesion/cytoskeletal linkage represents a novel strategy to
stimulate cardiomyocyte proliferation following ischemic injury.

Public health relevance
Project Narrative: Successful completion of this project will enhance our understanding of how cardiomyocytes transduce mechanical information from its neighbors and the surrounding extracellular matrix into biochemical signals that regulate myocardial proliferation. Moreover, successful execution of pre-clinical studies testing FDA approved drugs that target the N-cadherin-cytoskeleton connection may provide benefit to heart failure patients in the very near future.